The Role of CD4+ Memory T cell Subtypes in Periodontal Disease Recurrence

Project Summary
The recurrence of periodontal disease (PD) is a poorly immunologically defined or therapeutically targeted
clinical challenge. Uncovering the homeostatic and pathogenic potential of long-term immune cells in
periodontal tissues is crucial to revealing the cellular drivers of PD recurrence. This proposal focuses on
an overlooked periodontal-associated cellular compartment, CD4+ T memory cells (TM), which can readily
recognize microbial antigens for a quick and robust response. For this purpose, we will utilize a newly
characterized murine model of recurrent PD and a method for gingival T-cell enrichment. In this model,
time is a critical variable for recognizing disease initiation, resolution, and recurrence. By establishing this
model, we will be able to define a “recovered” baseline instead of a “healthy” baseline state, which is more
clinically accurate. Also, it allows defining how multiple relapse episodes incrementally impact the complex
periodontally-associated immune network. The preliminary studies revealed that CD4+ TM developed in the
gingiva soon after birth due to increasing environmental antigenic exposure. While the mice fully recovered
from ligature-induced PD, the bone loss rate accelerated during PD recurrence. Most intriguingly, CD4+ TM
subtypes are enriched in the gingiva during PD recurrence. Gingival CD4+ tissue-resident memory cells
induced bone loss when circulating T cell infiltration was inhibited. Based on these findings, we will test the
hypothesis that the PD-induced generation and persistence of CD4+ TM subtypes determine PD
recurrence. Thus, targeted depletion of these cells by inhibiting metabolic checkpoints will enhance
immune-regulatory responses and inhibit PD recurrence. There are three interconnected but independent
Aims: 1) To identify the spatiotemporal development of CD4+ TM cells in periodontal tissues. Here, the
focus will be on understanding the constitutive and pathologic generation of CD4+ TM cells to determine
their roles in the gingival immune landscape. 2) To elucidate PD-induced CD4+ TM pathogenicity. Here, we
will evaluate which CD4+ TM subtypes retain pro-inflammatory and osteoclastogenic programming after
PD. We will make transcriptomic comparisons between CD4+ TM subtypes and assess the findings with ex
vivo functional assays to validate their pathogenic potential. 3) To develop an intervention strategy for CD4+
TM depletion to prevent PD recurrence. Here, we will employ a metabolic-based strategy to selectively
deplete PD-induced CD4+ TM and enhance regulatory T cells enrichment to prevent PD recurrence. The
independence award (PAR-22-041) will foster my independent research growth and allow me to accomplish
my long-term career goal to become a productive, independent translational scientist in periodontology and
related fields focused on chronic diseases’ recurrence.

Public health relevance
PROJECT NARRATIVE Periodontitis is characterized by episodic recurrence throughout the patient's life, a growing global public health problem due to its bidirectional association with general health. This project will identify the generation, persistence, and pathogenic role of periodontitis-induced CD4+ memory T cell subtypes in a model of recurring periodontal disease. Using a novel T cell periodontal enriching strategy, we will dissect the functional properties of constitutively versus pathologically developed CD4+ memory T cells and assess the therapeutic potential of targeting these cells to prevent periodontitis recurrence.